Methods Core

SUMMARY – CORE C

There is extensive unexplained geographic and organizational variation in health care utilization and outcomes
across the United States. Many health policy experts view the reduction of unwarranted variation to be
essential in improving health care quality and reducing costs. Previously, individual heterogeneity of clinicians,
hospitals, and health systems has been studied as a possible determinant of such variation. However,
substantial variation is left unexplained. We hypothesize that the best way to make further inroads is in the
context of clinician networks and that the array of professional relationships between clinicians across the U.S.
is the mechanism for the diffusion and dissemination of best-­practice (high value, low cost) and worst-­practice
(ineffective and expensive) care. Unfortunately, it has proven challenging to measure professional networks
among U.S. providers. The Methods Core will meet this challenge by (i) measuring relationships from patient-­
clinician encounters in Medicare claims data using methods that make greater use of the information contained
in them than previously, (ii) computing network measures and statistical models involving them for the entire
U.S. social network, and (iii) using advanced computing to implement computations on the entire network in
feasible time. Advances in statistical methods for modeling hierarchically structured data and causally-­
defendable comparative effectiveness research will also be made. These methodological innovations support
and enhance the five projects, providing them the basis to delve deeper into their various lines of enquiry than
would be possible otherwise.